NIDA CTN Big South/West Node Rev13 Yr18 S1 MURB

ABSTRACT
The CTN-0110 MURB study is a 12-week randomized, double-blind, placebo-controlled Phase IIb trial that will
investigate the use of injectable buprenorphine (BUP-Inj) compared to injectable placebo (PBO-Inj) for the
treatment of methamphetamine use disorder (MUD) among individuals with mild co-use of opioids or opioid
misuse not warranting medication for opioid use disorder (MOUD). Participants will complete all study-related
tasks over a period of 19 weeks (up to 3 weeks for screening, 12 weeks for the medication phase, and a
follow-up safety visit at Week 16).The study intervention is 3 doses of 300mg BUP-Inj (or PBO-Inj) delivered by
abdominal subcutaneous injection at Weeks 1, 5 and 9. The primary objective is to evaluate whether
assignment to 12 weeks of outpatient BUP-Inj compared to 12 weeks of outpatient PBO-Inj reduces
methamphetamine (MA) use as measured by twice-weekly urine drug screens (UDS) during Weeks 9-12. For
the primary statistical analysis, generalized estimating equations will be used to model the log-odds of a MA-
negative UDS during Weeks 9-12, assuming an autoregressive lag-1 working correlation matrix. The robust
(sandwich) estimator will be used to adjust the covariances for the correlation of UDS from the same
participant. Missing UDS are imputed as MA-positive.

Public health relevance
PROJECT NARRATIVE From 2012 to 2018, overdoses associated with stimulants including methamphetamine have increased nearly five-fold 1. Aside from methamphetamine’s detrimental health effects, its use also has severe social consequences: interactions with the criminal justice system 2, homelessness 2, and increased domestic violence 3. This study will assess injectable buprenorphine as a pharmacologic treatment for methamphetamine use disorder.